Instrument Supplement: Mechanisms of Mechanotransduction by LIM Domain Proteins

Project Summary
Mechanisms of Mechanotransduction by LIM Domain Proteins
Mechanical forces are essential to controlling the shape, movement and even many
aspects of cell physiology. Changes in the environment mechanics or defects in cellular
mechanoresponse are implicated in a plethora of diseases including atherosclerosis,
heart failure and cancer. A major challenge is to understand mechanotransduction - the
mechanisms by which mechanical information is detected and communicated to
pathways that control cell behavior. The LIM super family of proteins, which contain one
or more LIM domains, represents a large number of putative mechanosensitive cellular
proteins that are involved in physiological mechanotransduction pathways.
Understanding how the LIM domains function to detect and transmit information about
mechanical stress will result in a deeper understanding of mechanotransduction-based
signaling, which is important for developing strategies of disease treatment and organ
regeneration.
This proposal leverages an innovative combination of cell biophysics, biochemistry
molecular cell biology, live cell imaging and mathematical modeling to investigate the
mechanism by which LIM domains sense mechanical stimuli in the actin cytoskeleton
and, in turn, initiate YAP/TAZ mechanotransduction signaling. We recently discovered
that a large number of LIM domains exhibit force-sensitive binding to actin filaments. Here
we propose to: (1) identify the mechanism by which LIM proteins are recruited to
mechanically stressed actin filaments, (2) determine how the LIM sequence enables
specificity in force-dependent recruitment within the actin cytoskeleton and (3) elucidate
how the mechanosensing by LIM protein LIMD1 initiates the YAP/TAZ
mechanotransduction pathway. These studies have the potential to demonstrate a highly
conserved mechanism of cell mechanosensing, and the methodologies will establish a
novel strategy for tackling cell mechanotransduction.

Public health relevance
PROJECT NARRATIVE A fundamental challenge in modern cell biology is to understand how cells sense and process mechanical signals to alter their physiology. We propose a multi-disciplinary strategy to reveal the mechanism by which LIM domain proteins control mechanotransduction pathways in epithelial tissue. These experiments will elucidate the mechanism by which LIM domains bind to mechanically stressed actin filaments, the force-dependent sorting of LIM proteins to within adherent cells and control ofYAP/TAZ. mechanotransduction signaling by the LIM protein LIMD1 in epithelia.